Core A -Administrative & Biostatistics Core

PROJECT SUMMARY –ADMINISTRATIVE AND BIOSTATISTICS CORE (CORE A)
The overall goals of the Administrative and Biostatistics Core (Core A) are to 1) continue to provide a structure
pto facilitate effective interactions leading toward the accomplishment of the aims of this Program Project Grant
(PPG) and specifically to foster and promote the goals of the Program and each component (cores and projects)
by providing scientific direction, administrative and budgetary support, oversight and integration of program
activities, and by ensuring operational efficiency; and 2) to continue to provide biostatistics and other statistical
support for the PPG. The following are the objectives of Core A: 1) provide research direction by setting the
research agenda focused on the discovery of novel small-molecule chemicals from selected higher plants, as
well as lichens, cyanobacteria and filamentous fungi, for development as cancer chemotherapeutic agents,
particularly for tumors not cured by present treatment methods. 2) Ensure operational efficiency for Program
components by providing centralized grant administration, information dissemination, budget data processing,
and exchange of information and services. 3) Promote integration of the Research Projects and Cores to
promote interaction among the three primary universities represented by the investigators, and relevant external
entities and 4) provide biostatistics support for the three Projects and the two service Cores of the PPG
Program. Core A will continue to ensure that all components of the Program work seamlessly together to
accomplish the overall and specific project goals of the PPG Program.

Public health relevance
PROJECT NARRATIVE –ADMINISTRATIVE AND BIOSTATISTICS CORE (CORE A) The primary purposes of the Administrative and Biostatistics Core are to provide overall administrative and biostatistical support to all other components of this Program Project. This Core is essential to the success of the investigations proposed in this renewal proposal.